Search for the Structural Basis of Biomacromolecular Function and Activity

During the past year, we have been focusing on four areas of research. 1. Study structural biology of the Rev response element (RRE); 2. Develop new inhibitor targeting the HIV-1 viral RNA; 3. Continuing the study of the conformational space of adenine riboswitch; 4. continuing the development of a technology for selective labeling of RNA molecules. The followings are the progress and summary of the studies in these four areas. 1. We have determined a low resolution structure of the RRE RNA and the finding has been published. 2. Based on the structure that we have reported, we have developed a new class of inhibitors targeting the RRE RNA. The new inhibitors bind to the RRE RNA with at least 10-fold higher affinity than the viral Rev protein, the natural ligand of the RRE RNA. A provisional patent has been filed based on this study. 3. We have used NMR, small angle X-ray scattering and single molecule Forster Resonance Engergy Transfer (smFRET) experiment to characterize the conformation space of the adenine riboswitch. Our results revealed that the binding pocket changed its conformation in response to ligand binding and that the distal loop-loop interaction of Adenine riboswitch aptamer restricts the conformational freedom of the three-way junction to promote ligand binding. Furthermore, the ligand binding also restricts the freedom of three-way junction to promote the distal loop-loop interaction under physiological conditions. These results provide an integrated view of hierarchical folding in atomic levels in an adenine riboswitch aptamer as a function of ligand and ion concentration. We are at the final stage of completing the project and have written the first draft of a manuscript to report the study. 4. My group has developed a new method for selective labeling of RNA (SLOR) at designated residue(s) and/or segment(s) of large RNAs using solid-phase multi-cycle enzymatic reactions. Currently, we have filed a provisional patent for the SLOR technology and a draft of the manuscript has been written.